Brain Attack Surveillance in Corpus Christi (BASIC) Project

Abstract
For a quarter of a century, the Brain Attack Surveillance in Corpus Christi (BASIC) Project has continued to
assemble a cohort of over 11,000 persons with stroke in a biethnic Texas community to study health equity and
the social determinants of stroke and stroke outcomes. This population-based project focuses on Mexican
American persons, the largest sub-group of Latinx, the United States’ largest minority population. In the newest
cycle, BASIC will continue to monitor trends and ethnic disparities in stroke incidence, recurrence, 90-day
outcomes (neurologic, functional, cognitive, and quality of life) and all-cause mortality. Because of previous
work suggesting a rising incidence in those 45-59 years of age, for the first time, BASIC will expand stroke
surveillance and outcome assessments to include those 35-44 years of age, where preliminary data suggests
that there is considerable stroke burden. Novel and innovative for this cycle of BASIC is a new mixed methods
focus on risk and resilience mechanisms among Mexican American stroke survivors to determine factors that
lead to better stroke outcome. Utilizing a modified Reserve Capacity Model, we will investigate barriers and
facilitators to favorable stroke outcomes and utilization of post-stroke healthcare among Mexican American
stroke survivors. The Reserve Capacity Model is a framework to examine the role of psychosocial factors in
health and health disparities including sociocultural and other resilience factors (e.g., reserve capacity
resources) that may be associated with better health outcomes. We will adapt this model to the stroke context
and to the unique cultural features of the Mexican American study community. This will be paired with a
rigorous qualitative investigation of available resources and unmet needs for favorable stroke outcomes among
Mexican American stroke survivors, including those 35-44 years of age. The previous cycle of BASIC saw the
beginning of an exciting linkage of our population-based study with administrative data creating a unique “big
data” resource. We now propose an innovative expansion of this effort and for the first time in addition to
Medicare data, we will link BASIC data to Medicare Advantage, Medicare Part D and Medicaid data. These
data linkages will be used to identify barriers and facilitators to post-stroke healthcare utilization, including
emergency department visits, readmissions, use of long-term care, primary care visits, mental health visits and
use of inpatient rehabilitation. Together, this next BASIC cycle will continue to monitor emerging stroke trends
and ethnic disparities while exploring several new avenues directed at uncovering specific targets to improve
Mexican American stroke health equity.

Public health relevance
Project Narrative This project extends the highly successful Brain Attack Surveillance in Corpus Christi (BASIC), the only population-based stroke study in Mexican Americans, to study thirty-year stroke epidemiology trends. For the first time, BASIC will move beyond a focus on ethnic group differences and employ a within-Mexican American design and qualitative methods to identify key factors and social determinants of health associated with more favorable stroke outcomes and utilization of post-stroke healthcare. The results will give insight into new ways to reduce ethnic stroke disparities.